FRESH Network: Assisting Mansfield Schools with Understanding Contanimants in School Meals and Transitioning to Better Food Systems

Project Abstract
Mansﬁeld School District (Arkansas)
FRESH Network: Assisting Mansﬁeld Schools with Understanding Contaminants in
School Meals and Transitioning to Better Food Systems
Across Arkansas and much of the country, school meals are often heavily reliant on ultra-
processed foods—items high in sodium, additives, and preservatives that can negatively
impact children’s long-term health and cognitive development. At the same time, Arkansas
is a state rich in agricultural resources, presenting a powerful opportunity to reimagine
school food systems using local, scratch-cooked, and nutritionally dense meals.
This project, supported by the FDA Research Study of Contaminants in School Meals
(U18), will pilot a transformative school meal model in participating districts across
Arkansas. The project includes nutritional and contaminant testing of both vendor-
supplied and scratch-cooked meals, robust student engagement through taste tests and
surveys, and professional development for school nutrition teams. Funding will also
support the purchase of critical equipment like combi ovens, the integration of farm-fresh
ingredients, and the development of aligned curriculum for CTE and health-related
classes.
Led in partnership with Wellness in the School, Thaden School and Healthy Flavors
Arkansas, the project will generate data-driven insights on student preferences, meal
quality, and health outcomes. The initiative aims to empower schools to improve food
safety, nutrition, and engagement while fostering sustainable, community-rooted food
systems that can serve as a national model.

Public health relevance
Project Narrative Mansﬁeld School District (Arkansas) FRESH Network: Assisting Mansﬁeld Schools with Understanding Contaminants in School Meals and Transitioning to Better Food Systems Mansﬁeld Public Schools in Arkansas have aligned with a group of partners that will support the district in understanding contaminants in school meals and in piloting a transformation to more scratch cooking. A research study will explore and document the school’s and its student’s experiences, measuring the impact of student engagement, meal consumption, impact on the community and on kitchen staﬀ. Importantly, the district will build relationships and supply chains with local farmers that ensure sustainability of this transformation over time. Mansﬁeld’s project partners include Wellness in the Schools, Healthy Flavors Arkansas, the Thaden School and the University of Arkansas Cooperative Extension Service.